Hybrid Effectiveness-Implementation Trial of a School Clinician Training and Psychosocial ADHD/ODD Intervention Program Adapted for Schools across Mexico (CLS-A-FUERTE)

Neurodevelopmental disorders of Attention-Deficit/ Hyperactivity Disorder (ADHD) and Oppositional Defiant Disorder (ODD) are extremely common but underserved with Evidence-Based Treatments (EBT) worldwide. Thus, our team developed, implemented and evaluated a school clinician training and ADHD/ODD intervention (i.e., the Collaborative Life Skills [CLS] program) for Mexico: a setting with high unmet need. We integrated technology into our in-person program (CLS-FUERTE) to create a digitally-enahnced version (CLS-R-FUERTE). Given findings demonstrating feasibility, acceptability, and efficacy of both program versions, we propose a Type 2 Hybrid Effectiveness-Implementation Design to evaluate the program effectiveness, mechanisms of intervention change, and maintenance barriers/facilitators in a scaled-up cluster randomized controlled trial with n = 40 schools across two Mexican -while also- exploring the impact of an implementation strategy in which we adapt the program to fit each school’s needs/resources during the maintenance period to encourage sustainability (i.e., CLS-A-FUERTE). Our implementation process is guided by the Exploration, Preparation, Implementation, and Sustainment (EPIS) model with evaluation following the Reach, Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) Framework.
Aim 1) Test the effectiveness and implementation of the CLS-A-FUERTE school clinician training and ADHD/ODD intervention program adapted for schools across Mexico. We expect:
H1) School clinicians will engage in training and implement chosen intervention components with fidelity
H2) Teachers and/or families will engage in chosen intervention components and adhere to the strategies
H3) Students receiving CLS-A-FUERTE will show greater improvement in ADHD/ODD symptom and impairment severity (rated by parents/teachers) compared to students receiving school services as usual
Aim 2) Evaluate mechanisms of sustained intervention change. We expect:
H4) Improvements in parenting behaviors will mediate sustained intervention effects
H5) Improvements in teacher and/or school clinician competency will mediate intervention effects
Aim 3) Identify CLS-A-FUERTE maintenance barriers and facilitators. We expect across adaptations that sustained intervention effects and continuation of program activities at follow-up will relate to:
H6) Program feasibility (i.e., cost estimates) and acceptability (i.e., participant satisfaction)
H7) Characteristics of participating schools and school context factors
Aim 4) Expand research capacity to a novel university setting. We expect emerging investigators will:
H8) Complete clinical research coursework and produce deliverables (i.e., presentations, papers, grants)
H9) Show improved EBT skills, research capacity and culture ratings, and competency as program trainers

Public health relevance
Project Narrative Neurodevelopmental disorders of inattention and disruptive behavior, such as Attention-Deficit/ Hyperactivity Disorder (ADHD) and Oppositional Defiant Disorder (ODD), are among the most common youth conditions worldwide with prevalence estimates at 7% for ADHD and 10% for ODD in Mexico. Left untreated, they contribute to a host of adverse consequences, costing our global society hundreds of billions of dollars each year. Investigating the effectiveness and implementation of feasible, flexible, sustainable, and scalable school clinician training and evidence-based treatment programs supported by clinical research capacity building efforts has the potential to combat the widespread impact of ADHD/ODD, as well as inform future studies of other evidence-based clinician training and intervention programs in real-world, high-need global contexts.